Modernization, Expansion, and Development of the Lifelong Interdisciplinary Movement, Biomechanics, and Respiration (LIMBR) Center

PROJECT SUMMARY
Our infrastructure proposal titled “Modernization, Consolidation, and Development of the Lifelong
Interdisciplinary Movement, Biomechanics, and Respiration (LIMBR) Center,” will develop centralized facilities
to enable and enhance the conduct of high impact and innovative biomedical research at Boise State
University to improve U.S. health. The long-term goal of our proposal, “Modernization, Consolidation, and
Development of the Lifelong Interdisciplinary Movement, Biomechanics, and Respiration (LIMBR) Center” is to
develop a national hub for excellence in multidisciplinary human movement research across the lifespan. The
proposed construction will improve and consolidate institution-wide human movement and respiratory research
facilities to increase and advance biomedical research, collaboration, and long-term sustainability in both the
Intermountain West Region and the greater U.S. The LIMBR Center’s unique intersection of respiration and
musculoskeletal health addresses a critical gap: posture and movement directly influence pulmonary function
throughout the lifecycle, yet no existing facilities in the U.S. comprehensively integrate these disciplines. Our
current lab supports the biomechanics research efforts of humans throughout the lifecycle (infants to athletes
to elderly). However, the limitations of our current shared lab space include an off-campus location, a retro-fit
office building without proper infrastructure, and an inability for research groups to conduct simultaneous
studies. These infrastructure-related limitations are prohibiting additional growth, collaboration, innovation, and
sustainability of our human movement and respiratory research. These significant barriers will be overcome
with our proposed infrastructure project to refurbish our centrally located and decommissioned aquatic center
into a premier human movement laboratory. The new centrally located LIMBR Center will be designed
specifically for human movement and respiration research, and will feature two distinct motion capture lab
spaces which can be used as a single large lab, or partitioned into separate labs to facilitate simultaneous data
collections amongst multiple investigators. We will also have a separate respiratory lab, a clinical exam room, a
mechanical lab, and space for a future medical imaging lab. This project will enhance institutional-wide
research programs and benefit numerous research groups. Current studies of humans throughout the lifespan
which will benefit from this infrastructure improvement include infant product safety, assessment of post-
concussion injury, early detection of stress fractures, and fall-prevention for older adults. We have specific
projects planned with investigators across campus from Radiological Sciences, Respiratory Care, Materials
Science, Engineering, Kinesiology, and Athletics, as well as regional and national clinical partners. With the
support of our regional Institutional Development Award (IDeA) network and programs, this proposal will
elevate us to a premier sustainable site for human movement and respiration research across the lifespan, and
will enable us to take part in nationwide multicenter studies to improve the health and wellness of the U.S.